A phospho-tyrosine-based signaling module controlling TLR-mediated inflammatory disease.

ABSTRACT
Toll-like receptor (TLR)-mediated inflammation initiates physiological immune responses; however,
inappropriate TLR activity leads to immune pathology as observed in inflammatory diseases, such as systemic
lupus erythematosus (SLE). Various proteins acting in the TLR pathway, such as the Src kinase LYN and the
transcription factor IRF5, are genetically linked to SLE. Related mouse models confirm their critical roles. LYN-
deficient mice develop a spontaneous lupus-like disease that is rescued by genetic deletion of IRF5 or the up-
stream acting TLR adaptor protein MyD88. As such, LYN is an important negative regulatory protein, while IRF5
promotes lupus inflammation. Still, the molecular mechanisms acting between TLR/ MyD88, LYN and IRF5 are
incompletely understood. In preliminary studies, we found that MyD88 controls LYN activity via a sequence of
defined protein interactions, which inhibit LYN during TLR stimulation and thus allow for IRF5 activation.
Accordingly, point mutations of key interacting surfaces in cell lines results in uncontrolled LYN activity and
inhibition of IRF5 activation. This mechanism is coupled with tyrosine phosphorylation events between MyD88,
LYN and IRF5 and a hitherto undefined E3 ubiquitin ligase that controls pathway activity. Based on these
observations we hypothesize that this mechanism is essential to maintain the balance between TLR-driven
physiological and pathological inflammation. While these observations are based on extensive biochemical
analyses, they raise important questions as to (i) the in vivo relevance of this pathway, in particular for lupus-like
inflammatory disease and possible therapeutic implications and (ii) the mechanism of IRF5 regulation, in
particular related to the unknown IRF5 E3 ligase.
In this project, we will investigate three novel knock-in (KI) mice with defined point mutations controlling
mentioned protein interactions. If our hypothesis is correct, two of these point mutations (acting upstream of
LYN) will prevent TLR-driven lupus-like disease in mouse models due to inhibition of IRF5, while one mutation
(acting downstream of LYN) is expected to mediate an IRF5 gain-of-function phenotype and thus drive lupus
pathology. We will use a biochemical approach based on quantitative mass spectrometry to identify the
mentioned, hitherto undefined E3 ligase.
Collectively, we expect that this work will establish the described protein interaction and phosphorylation
cascade as key TLR-regulatory mechanism. Given the central function of TLRs and IRFs in many physiological
and pathological conditions, we expect that the significance of results obtained in this project reaches beyond
IRF5 and lupus biology.

Public health relevance
PROJECT NARRATIVE Systemic lupus erythematosus (SLE) is a chronic inflammatory disease with clear contribution of so-called Toll- like receptors (TLR); however, the mechanism how these receptors contribute to disease is incompletely understood. Based on detailed biochemical studies, we found a novel mechanism (pathway) how TLRs activate genes that are known to drive SLE. In this project, we will further study this pathway on a molecular level and establish its relevance for human SLE by using sophisticated novel mouse models, hopefully revealing a key mechanism that controls SLE as potential therapeutic target.